Hybrid Effectiveness-Implementation Trial of a Nurse-Led Firearm Safety Intervention in the Pediatric Inpatient Setting

PROJECT SUMMARY
The proposed study aims to reduce firearm-related deaths in children by scaling out an evidence-based secure
firearm storage intervention. The rate of firearm-related deaths increased by 41% from 2018-2021 across all
intents, and firearms are now the leading cause of death for youth ages 1-19. Secure firearm storage is a health
behavior that is critical for reducing unauthorized access to firearms and the risk of suicide, homicide, and
unintentional injuries. S.A.F.E. Firearm is an evidence-based intervention that includes (1) brief, parent-directed
discussion on secure firearm storage using a motivational interviewing and harm reduction approach and (2)
free cable locks offers to all parents during well child visits in pediatric primary care. Importantly, S.A.F.E. Firearm
has potential to save lives beyond primary care, and pediatric inpatient settings are an advantageous context for
S.A.F.E. Firearm implementation. Across the U.S. there are over 250 children's hospitals, approximately two
million children are hospitalized yearly, and parental engagement is a core feature of care. Moreover, hospitals
are essential settings for children disadvantaged by structural determinants and inadequate access to outpatient
services. Children's Hospital of Philadelphia (CHOP) is a large, nonprofit pediatric health care system with two
freestanding children's hospitals in the greater Philadelphia region. Our team has pilot tested firearm safety
initiatives in the emergency department, select primary care sites, and the pediatric intensive care unit. Through
our formative work, we have identified bedside nurses as vital potential implementers. In Aim 1 of this proposal,
we will adapt S.A.F.E. Firearm for the pediatric inpatient setting and nurse-led delivery using intervention
mapping. Anticipated products are an adapted intervention and optimized bundle of implementation strategies.
In Aim 2 we will conduct a parallel cluster randomized hybrid Type 2 effectiveness-implementation trial across
two CHOP hospitals. Twelve inpatient nursing units will be randomized to receive adapted S.A.F.E. Firearm or
usual care, defined as routine clinical care plus free cable locks available in the hospital safety center. We will
test whether parents exposed to adapted S.A.F.E. Firearm report greater improvements in secure storage
(primary outcome) compared to parents exposed to usual care over one year of active implementation.
Secondary outcomes are additional firearm safety behaviors (e.g., firearm removal). We anticipate 14,400
eligible patient visits across the 12 units. Guided by the RE-AIM framework with equity considerations, we will
examine the effect of the implementation strategy bundle on S.A.F.E. Firearm outcomes in Aim 3. Our primary
implementation outcome is reach (i.e., electronic health record-documented program delivery). Secondary
outcomes include fidelity, acceptability, and maintenance. We will explore implementation strategy mechanisms
via qualitative interviews with nurses. Aligning with NINR priorities related to reducing injury inequities and
promoting population health, our findings will accelerate research translation and serve the broader goal of
reducing firearm-related mortality and improving health for children and their families.

Public health relevance
PROJECT NARRATIVE This proposed study has important potential to impact public health and reduce youth firearm-related deaths by scaling out an evidence-based secure firearm storage intervention to pediatric inpatient hospital settings. This cluster randomized clinical trial will test both the effectiveness of an adapted secure firearm storage intervention in improving parent-reported secure storage and secondary firearm safety behaviors, as well as examine the effect of an implementation strategy bundle on intervention reach, acceptability, fidelity, and maintenance. Nurses will lead implementation, highlighting an opportunity for widescale impact by harnessing the expertise of frontline nurses in the work of firearm injury prevention.